Mechanisms of TGF-β-induced resistance to proteasome inhibitors in multiplemyeloma

PROJECT SUMMARY/ ABSTRACT

Multiple myeloma (MM) is the second most common hematologic malignancy and remains incurable in the vast
majority of patients with a median survival of 5-­7 years. While FDA-­approval of proteasome inhibitors (PIs) in
combination with immunomodulatory agents and traditional drugs has significantly improved patient outcomes,
the development of PI-­resistance remains a primary reason for patient demise. There is also a significant fraction
of newly diagnosed MM patients who are refractory even to PIs and have not benefited from recent therapeutic
advancements. The transforming growth factor (TGF)-­β pathway is a key driver in cancer and TGF-­b-­responding
cells resist anti-­cancer therapeutics leading to drug resistance, tumor recurrence and reduced survival.
Understanding the mechanistic role of TGF-­b1 to promote acquired PI-­resistance in MM represents a clinically-­
relevant gap in knowledge and an unmet need and immediate translational impact. Here, we evaluated the TGF-­
b type I receptor (TGF-­bRI) as a new target for clinical application in MM and the biological effects of the TGF-­
bRI inhibitor Vactosertib on PI-­resistant MM cells.
Elevated TGF-­b1 levels in MM patient sera correlates with
chemoresistance, disease progression, metastasis and poor prognosis. TGF-­b1 also upregulates the expression
of PSMB5, the proteasome catalytic subunit that is inhibited by PIs. TGF-­b1 also induces the accumulation of
myeloid-­derived suppressor cells (MDSCs) within the tumor microenvironment. These observations led us to
explore the potential for Vactosertib to disrupt the TGF-­b pathway and, thereby, overcome tumor intrinsic and
extrinsic mechanisms of PI-­resistance in MM. Vactosertib is a recently developed, novel, orally available small
molecule inhibitor of TGF-­βRI kinase activity. Our results show that Vactosertib reduces PSMB5 expression and
proteasomal catalytic activity in MM cells, reduces the growth and induces apoptosis of MM cells, suppresses
myeloma growth in murine models in vivo and in combination with PIs overcome drug resistance. In the proposed
studies, we will first determine the effect of TGF-­b1 on the expression of proteasome genes and subunits in PI-­
sensitive and resistant MM cells and MM patient tumor cells (Aim 1).
We will then determine the effect of
Vactosertib on the level of proteasome subunits in MM cell lines and patient tumor cells. We have utilized the
well-­characterized 5T33MM murine model to explore the impact of specifically targeting TGF-­β signaling on MM
progression. Our preliminary data reveal Schlafen-­4 (Shlf-­4) is a TGF-­β-­regulated gene associated with MM
progression, whose expression is abrogated by Vactosertib. We will determine the effects of Vactosertib on
MDSC depletion in 5T33MM mice, as well as the effects on MDSC functional activity and Shlf-­4 levels in MDSCs
(Aim 2). We will then validate the murine studies and determine the effect of Vactosertib on MDSCs and tumor
cells isolated from human MM patients. Successful pursuit of the specific aims will improve our understanding of
the mechanisms underlying acquired PI-­resistance in MM and facilitate the design of clinical trials to evaluate
the efficacy of Vactosertib combined with PIs.

Public health relevance
PROJECT NARRATIVE Public Health Relevance Statement: Our studies represent a new paradigm designed to target the TGF- b signaling pathway in multiple myeloma (MM) and has great promise not only to overcome proteasome inhibitor resistance and improve patient outcome but may also serve as a model for targeted therapeutics in other cancers. Our application represents the integrated efforts of individuals with a long track record of basic and clinical research expertise in MM to precisely determine how the TGF- b type I receptor inhibitor Vactosertib elicits tumor intrinsic and extrinsic anti- myeloma activity.